A role for RNA in sister chromatid cohesion at human telomeres

Project Summary
Telomeres, specialized structures comprised of TTAGGG repeats and the six-subunit shelterin complex, require
distinct mechanisms for their protection, replication, and cohesion. Following replication in S phase, sister
chromatids are held together (cohered) until mitosis when they are distributed to daughter cells. Resolution of
cohesion between sister telomeres requires the poly(ADP-ribose) polymerase, tankyrase 1. Tankyrase localizes
to telomeres by binding to the TTAGGG-repeat binding shelterin subunit TRF1, in late S/G2 to resolve cohesion.
In tankyrase 1 depleted cells sister telomeres remain cohered in mitosis (termed persistent telomere cohesion),
despite normal resolution of sister chromatid arms and centromeres. This proposal builds on our recent discovery
that persistent telomere cohesion serves a protective function (in the absence of telomerase) at critically short
telomeres. We found that reduction of TRF1 (and the consequent tankyrase deficiency) at shortened telomeres
in aged cells (or telomeres negative cancer cells) prevents resolution of cohesion and that this (unexpectedly)
serves a protective role to prevent premature senescence or growth arrest. We will elucidate the mechanisms,
which we show are RNA-based. Our identification of RNA-binding proteins as a significant group of tankyrase
interactors in a proteomic screen prompted an investigation into a function for RNA in cohesion. Indeed, we have
uncovered a role for the long non-coding telomere repeat-containing RNA (TERRA) in persistent telomere
cohesion. We show that accumulation of TERRA and TERRA R-loops (RNA/DNA hybrids) occurs concomitant
with persistent telomere cohesion to protect critically shortened telomeres. We will elucidate the proteins and
pathways required to reduce TERRA levels for resolution of telomere cohesion, determine their role in ensuring
protection of short telomeres in presenescent cells, and explore a potential phase transition mechanism used by
tankyrase to resolve telomere cohesion. Our study provides a unifying and novel mechanism that relies on RNA,
R-loops, and persistent telomere cohesion to buffer shortened telomeres and promote genome integrity.

Public health relevance
Project Narrative Telomere shortening drives genome instability in aging and cancer. The shortening process is tightly monitored to prevent a DNA damage response and premature cell cycle arrest. Mechanistic understanding of this process and the role of RNA will provide insights to prevent premature senescence in aging cells and to promote premature death in ALT cancer cells.